Disordered Proteostasis as a Driver of Disease in the Aging Lung

PROJECT SUMMARY_OVERALL
The Geroscience hypothesis is based on the observation that healthspan decline toward the end of life
often presents with a single age-related illness that is followed by rapid accumulation of age-related
complications over a relatively short period. According to this hypothesis, treating any one of these conditions
without treating the fundamental biology of aging will only result in its substitution by another. The discovery
of therapies that target aging biology to improve resilience and reduce frailty address the geroscience
hypothesis, but administering these therapies based exclusively on chronological age will inevitably result
in overtreatment. While pneumonia is more common and more severe in the elderly, most older patients with
access to modern health care survive their illness. However, in the year after hospital discharge these older
pneumonia survivors have an increased risk of developing age-related disorders including persistent lung
injury, skeletal muscle dysfunction leading to immobility, dementia, and cognitive impairment. As such,
pneumonia is a gateway for the compounding morbidity that limits healthspan at the end of life. We therefore
reason that interventions that target aging biology to improve repair and promote resilience administered
during recovery from pneumonia or other environmental stressors in the elderly will have broad impact.
Proteostasis refers to the dynamic process by which cells control the concentration, conformation, binding
interactions, and stability of individual proteins making up the proteome. In the first cycle of this award,
the PPG investigators have generated substantial published and preliminary data supporting the central
hypothesis of this PPG that advanced age is associated with impaired recovery from pneumonia, and
metabolic interventions targeting complex I of the mitochondrial electron transport chain can reverse these
changes by restoring proteostasis through the integrated stress response and ATF4. To address this
fundamental question in aging, the project investigators will focus on tissue recovery after infection with the
influenza A virus in mice, a clinically relevant model that can be rigorously applied across the entire lifespan and
which recapitulates human biology on a time frame that can be studied in the laboratory. We will test this
hypothesis in three interrelated projects/aims:
Aim 1. To determine whether age-related impairments in the reparative function of alveolar macrophages can
be reversed by transient low level inhibition of electron transport with complex I inhibitors via the ISR and ATF4.
Aim 2. To determine whether inhibition of mitochondrial electron transport at complex I over the lifespan
drives the age related impairment in recovery after influenza A pneumonia.
Aim 3. To determine whether the impaired scavenger receptor function of aged resident skeletal
muscle macrophages and microglia can be reversed by inhibitors of complex I via the ISR and ATF4 to
improve motor and cognitive function after pneumonia.

Public health relevance
NARRATIVE_OVERALL Pneumonia is the most common cause of death from an infectious disease worldwide and disproportionately affects the elderly. Most elderly patients survive pneumonia, but they have an increased chance of developing ongoing lung inflammation, skeletal muscle dysfunction and cognitive decline. We show that metabolic interventions that restore proteostasis in older animals can accelerate recovery after pneumonia with implications for therapy.